Regulatory Mechanism of Cullin-RING Ubiquitin Ligases

ABSTRACT
Ubiquitination, the post-translational attachment of ubiquitin or ubiquitin chains, controls the stability, interaction
or activity of numerous key regulatory proteins in eukaryotic cells. Consequently, misregulation in protein
ubiquitination can result in various human diseases, such as metabolic disorders, cancers, muscle and nerve
degeneration. At the core of the ubiquitination process is the E3 ligase, which brings ubiquitin and the target
protein together, and enables the transfer of the ubiquitin to its target. My lab investigates the largest family of
E3 ligases, known as Cullin-RING ligases (CRLs). These enzymes are modular protein complexes, featuring a
common cullin scaffold and an interchangeable substrate receptor that recruits specific target proteins for CRL-
dependent ubiquitination and subsequent degradation. Seven cullins (Cul1-7) exist in human cells, each of which
interacts with different sets of substrate receptors, yielding ~250 CRLs. We use a variety of approaches including
biochemistry, biophysics, molecular genetics, quantitative proteomics, and mathematical modeling to study how
CRLs work, how their activities are regulated, and what critical roles they play in cells and organisms. Given that
a large number of substrate receptors compete for access to the same cullin, our current research focus is to
uncover how the cellular repertoire of diverse CRLs is controlled to ensure ubiquitination of various CRL
substrates at the right time. Using Cul1 based CRL1, we previously reported that CRL1s constantly undergo
cycles of assembly and disassembly, which allows rapid recycling of Cul1 and timely formation of new CRLs
when their target proteins emerge and demand ubiquitination. A crucial player in this highly dynamic process is
Cand1, a protein exchange factor that promotes the exchange of substrate receptors associated with the same
Cul1 core. Eliminating the Cand1 activity leads to impaired degradation of CRL1 substrates in human cells and
severe developmental defects in multicellular organisms. In this application, we ask, how are the dynamics of
other CRLs regulated? What role does Cand2, a homologue of Cand1 in human cells, play in regulating CRLs?
What advantage does this evolutionarily conserved dynamic exchange mechanism provide for the CRL system?
To answer these questions, we will use in vitro biophysical assays to quantify kinetic parameters for CRL and
Cand1/2 interactions. We will apply our updated quantitative immunoprecipitation-mass spectrometry assay to
characterize the impact of Cand1 and Cand2 on the cullin-associated proteome. We will employ genome-editing
techniques such as CRISPR to examine the biological role of Cand1/2, using cultured human cells and the model
plant Arabidopsis as our experimental systems. We will continue developing our mathematical model of CRL
assembly and activity, to help understand the CRL network in different cell types or under changing cellular
environment. Our efforts in understanding mechanisms regulating CRLs will help dissect the performance of
these E3 ligases in normal, diseased, and drug treated cells, providing novel insights for the prevention,
diagnosis, and treatment of human diseases.

Public health relevance
PROJECT NARRATIVE This project aims to understand mechanisms regulating the Cullin-RING ubiquitin ligases (CRLs), a large family of enzymes that control the activity and degradation of numerous critical regulatory proteins in human cells. Dysfunction and misregulation of CRLs can lead to various diseases such as cancers and muscle dystrophies, and a member of CRLs, Crbn, is responsible for the anticancer activity of the drug thalidomide. Our research findings will provide a foundation for understanding the pathogenesis of CRL-related diseases and inform novel strategies for the prevention and treatment of these diseases.